A Novel Multimodal Approach to Characterize NAFLD Severity and Prognosis

PROJECT SUMMARY
Nonalcoholic fatty liver disease (NAFLD) is an increasingly common cause of cirrhosis and on pace to be the
leading indication for liver transplantation in the United States.(1, 2) NAFLD presents as a spectrum of disease
ranging from isolated steatosis, which portends little risk of significant morbidity, to nonalcoholic steatohepatitis
(NASH), which is characterized by inflammation and cell death and has substantial risk of progression to cirrhosis
and liver-related mortality.(3) Unfortunately, liver biopsy remains the only way to accurately discriminate between
isolated steatosis and NASH; however the procedure is invasive and remains impractical to scale to the
estimated affected population of 60 million adults in the United States. Attempts to use individual or small
combinations of biomarkers to characterize risk in NAFLD have been largely unsuccessful leaving a tremendous
need for non-invasive risk stratification. My central hypothesis is that distinct subtypes of NAFLD can be identified
by combining multiple non-invasive biomarkers, genetic and clinical factors using advanced analytic techniques
for high dimensional data. Through my collaboration with the NIH-funded, multicenter NASH Clinical Research
Network (NASH CRN) I explored the association between 28 putative plasma biomarkers and NAFLD histology
and found that small sets of biomarkers were limited in discriminating between clinically significant stages of
histologic severity. However, by applying a novel statistical technique, latent class analysis (LCA), we generated
preliminary data identifying distinct subgroups of patients with NAFLD that are strongly associated with histologic
severity. The research goal of this application is to (1) combine clinical and dietary factors, genetic markers and
an expanded set of plasma biomarkers to refine distinct phenotypes of NAFLD using LCA, (2) validate the
association between LCA defined phenotypes and histologic severity in an independent cohort with biopsy
proven NAFLD, (3) build on an existing longitudinal cohort and test the ability of these phenotypes to predict
progression of fibrosis. My long-term goal is to combine expertise in multimodal, non-invasive biomarkers of
NAFLD with advanced analytic techniques to personalize the management and treatment of patients with
NAFLD. In order to accomplish this goal, I have assembled an exceptional mentorship team including my primary
mentor, Dr. Rohit Loomba, who is an internationally renowned expert in NAFLD and Director of the UCSD NAFLD
Research Center. In addition, Dr. Ariel Feldstein, Chief of the Division of Pediatric Gastroenterology, and an
expert in translating NAFLD pathophysiology into biomarker development will serve as a co-mentor. Professor
Lily Xu, biostatistical director of the UCSD Clinical and Translational Research Institute, will serve as my
biostatistical mentor. Together, we formed a four-fold career development plan to gain expertise in (1) cohort
development, biobanking and advanced NAFLD phenotyping, (2) statistical analysis of genetic and high
dimensional data, (3) NAFLD pathobiology and biomarker development, and (4) research dissemination and the
development of national recognition in the non-invasive assessment of NAFLD.

Public health relevance
PROJECT NARRATIVE Despite the increasing prevalence of nonalcoholic fatty liver disease (NAFLD), our ability to determine who has the progressive form of disease relies upon liver biopsy, which is an invasive test that is impractical to scale to the affected population. This project will build upon preliminary work demonstrating that applying advanced analytic techniques to a combination of multiple modalities of non-invasive markers including levels of plasma cytokines and clinical factors can help uncover distinct subtypes of NAFLD associated with disease severity. This study will non-invasively stratify the phenotypes of NAFLD into low versus high risk of disease progression, which is desperately needed in order to prevent excessive testing and potential morbidity for patients at low risk for progression and to focus interventions on the population at greatest risk.